An Improved Epigenetic Algorithm for Guiding Low Dose CT Lung Cancer Screening

SPECIFIC AIMS
Approximately 90% of lung cancer results from smoking. Low Dose Computerized Tomography (LDCT) of
smokers can detect lung cancer earlier allowing more effective treatment. But determining which smokers should
get LDCT screening is controversial and potentially harmful. Recently, the U.S Preventive Services Task Force
(USPSTF) updated their opinion on screening to recommend annual LDCT screening for current or recent
smokers between the ages of 50 and 80 who have smoked 20 pack years (PY) or more. In addition, they
specifically called for the development of biomarker-based methods to predict who will benefit from screening.
Precision Epigenetics may answer this call. In 2012, we showed that DNA methylation at cg05575921, a
site in the aryl hydrocarbon receptor repressor (AHRR) gene, predicts smoking status. Since then, over 100
studies have replicated those findings. In 2018, we developed Smoke Signature©, a precise, reference free
methylation sensitive digital PCR (MSdPCR) assay for this locus. In peer-reviewed publications, we have shown
that the Receiver Operator Characteristic (ROC) area under the curve (AUC) for this assay is 0.984 for daily
smokers, the amount of demethylation accurately predicts daily consumption and that the re-methylation
response to smoking cessation can be used to monitor success of cessation therapy.
Intriguingly, in 2017, Bojesen and colleagues showed that cg05575921 methylation also predicts those
smokers likely to benefit from LDCT screening. Recently, we have now confirmed and extended these findings
using a subset of DNA specimens from the National Lung Screening Trial (NLST). In particular for those NLST
subjects who reported quitting smoking, our method significantly predicts lung cancer risk better than PY alone
in a racial and gender-free manner. However, our method is based only the data from 3200 NLST subjects, all
of whom smoked 30 PY or more.
In this Phase II project, we propose to finish our assessments of the 4800 NLST subjects, all of whom have
> 30 PY of consumption and LDCT data, then use DNA from 4800 subjects in x-ray only arm of the NLST and
4800 subjects from the PLCO collection to extend the range of our test down to 20 PY of cigarette consumption.
We will then analyze the resulting data and develop a race and SES bias free Cox regression formula to predict
risk for those between the ages of 50-80 years and >20 PY of smoking. The resulting laboratory developed test
(LDT) will run on the 510K approved Bio-Rad QX-200 platform with reagents from companies that can comply
with FDA standards. When implemented, the test will decrease healthcare costs and morbidity and mortality
from unnecessary procedures. Eventually, we believe that this test will be essential for both prescreening
counselling and treatment monitoring of all smokers.

Public health relevance
Narrative The purpose of this application is to complete development of a DNA methylation test can help determine whether a smoker should undergo low dose CT screening for Lung Cancer and if this methylation test can help predict risk for cancer.